Regulation of membrane trafficking by Coronins

ABSTRACT
The extensive family of the Coronins plays an important role in regulating the actin
networks that drive cell migration, polarity, cell shape and intracellular trafficking, and
thereby contribute to essential biological processes ranging from innate immunity to
neuronal signaling. However, these functions and activities have been characterized for
the canonical Coronins. In stark contrast, we know next to nothing about the cellular
roles and actin cytoskeleton regulation of the structurally distinct class of the tandem
Coronins, which comprises Coronin 7 (Coro7), POD-1, and CorB. Our preliminary data
show that mammalian Coro7 can control Arp2/3-mediated nucleation, although the
mechanism underlying this activity remains elusive. In addition, we show that this actin-
regulatory activity can regulate NPF-induced actin networks that drive intracellular
membrane transport, including autophagy, a process used by cells to dispose of
unwanted organelles, misfolded proteins and toxic aggregates. Using a multidisciplinary
approach comprising state-of-the-art biochemical, biophysical, genetic and live-imaging
techniques we propose here to elucidate 1) how Coro7 structurally interacts with Arp2/3,
2) how Coro7 mechanistically inhibits Arp2/3-mediated nucleation by nucleation
promoting factors, and 3) by other Arp2/3 regulators, and 4) how these actin-regulatory
activities of Coro7 regulate the turnover of the branched actin networks that drive
autophagy.

Public health relevance
PROJECT NARRATIVE The subfamily of the tandem Coronins forms a structurally unique class among the extensive family of the Coronins, however to date their actin- regulatory functions remain completely unknown. Using a combination of single molecule techniques, protein crystallography, and cell biology, we will investigate how the mammalian tandem Coronin, Coro7, structurally and mechanistically inhibits Arp2/3-mediated nucleation induced by nucleation promoting factors (N- WASP, WHAMM, and JMY), and other Arp2/3 regulators, including GMF, and SPIN90. In addition, we will elucidate how these actin-regulatory activities of Coro7 work in concert with Arp2/3 and its various interactors in intracellular membrane transport and autophagy. Altogether, this proposal will shed light on the enigmatic actin-regulatory functions of the class of the tandem Coronins in vitro, and in cells.